Mechanisms Governing Uterine Epithelial Plasticity

Project Summary/Abstract
Unlike most other organs and tissues, the endometrium of the adult uterus has a remarkable regenerative ability,
undergoing repetitive cycles of proliferation, differentiation, breakdown, and regeneration. The endometrium is a
complex tissue comprised of stroma, vasculature and immune cells, as well as two major epithelial cell types —
luminal (LE) and glandular (GE) epithelium. Notably, the endometrium repairs after menstruation, injury, and
childbirth without scarring and then regenerates with full function to support pregnancy. Aberrations in
regeneration negatively impacts pregnancy success and can lead to infertility or diseases, such as
endometriosis, endometrial fibroids, Asherman’s syndrome, and endometrial cancer. Thus, the long-term
research objective is to define the critical intrinsic and extrinsic mechanisms governing uterine epithelial cell
differentiation and regeneration with subsequent impacts to diagnose, treat, and prevent infertility and
endometrial disease in women. The regenerative capacity and ability to grow ectopically (endometriosis)
suggests that the endometrium has a robust and plastic progenitor population. Indeed, numerous reports have
provided evidence that cells with stem cell-like qualities exist in the epithelium of the uterus; however, the identity,
behavior, and mechanisms underlying the fate of those cells and their location remains unclear. Ambiguity within
the uterine stem cell field may be partly because the strict lineage hierarchies that characterize development and
homeostatic tissue turnover are not followed during tissue repair. Recent studies in several organs found that
epithelial plasticity and activation of facultative stem cells are common strategies for tissue regeneration in the
injury repair process. Therefore, this proposal focuses more on the process used by the uterus to replace lost
cells, rather than on the physical entity of a stem cell. The overarching hypothesis is that the uterine epithelium
contains cells that are unipotent during normal homeostatic turnover but have the ability to dedifferentiate upon
injury to coordinate successful epithelial regeneration. Guided by strong preliminary data and the use of
innovative mouse genetic models, organoid culture, and single-cell sequencing technologies, two specific aims
will begin testing that hypothesis: (1) epithelial plasticity in the regenerating uterus; and (2) cellular and molecular
aspects of LE response to GE ablation. The outcome of the proposed studies will connect epithelial regeneration
responses to specific molecular mechanisms of epithelial differentiation and repair. In the long term, an increased
understanding of the cellular and molecular mechanisms that govern endometrial epithelial cell differentiation
and regeneration is important not only for gaining fundamental knowledge of tissue and stem cell biology but
also for the development of therapeutics for the treatment of endometrial diseases.

Public health relevance
Project Narrative The human and mouse endometrium can respond to acute or chronic injuries with scar-free regeneration. This application proposes an integrative set of studies that will define critical physiological and genetic pathways that regulate the remarkable regenerative capacity of the uterine epithelium upon injury. The results will significantly increase our understanding of endometrial epithelial differentiation and regeneration with subsequent impacts to diagnose, treat, and prevent infertility and endometrial disease in women.